Reducing the Transition from Acute to Chronic Musculoskeletal Pain among Older Adults

Project Summary
Chronic musculoskeletal pain is a major health burden for older adults in the U.S., decreasing quality of life,
increasing disability, and predisposing patients to long-term opioid use. One important cause of chronic pain
among older adults is persistence of acute traumatic or atraumatic musculoskeletal pain. Consistent with this,
the NIH has identified reducing the transition from acute to chronic musculoskeletal pain among older adults as
a research priority. Effective early treatment of acute pain is essential for preventing the transition to chronic
pain but is challenging in older adults for two reasons. First, the selection of analgesics is complicated by
contraindications and high rates of side effects and adverse events. Second, recovery promoting behaviors are
rarely explained to patients by providers and, as a result, rarely practiced by patients. Shared decision-making,
which involves the exchange of information between patients and providers to support treatment decisions,
provides an important clinical approach for improving the effectiveness and safety of the initial management of
pain in older adults. The proposed study will test a three component intervention to support shared decision-
making during the early recovery phase for older adults who present to the emergency department (ED) with
acute musculoskeletal pain. The first component is a brief interactive video to enhance patient knowledge and
self-efficacy regarding treatment options with the intent of facilitating conversations between patients and
emergency providers. The second component is a protocol-guided phone conversation (telecare) between a
nurse care manager and the patient 48-72 hours following ED discharge to assess pain severity and
interference with daily activities, review analgesic use and side effects and recovery-promoting behaviors, and
discuss adjustments to the patient's treatment. The third component is communication with the patient's
primary care provider following the telecare call to inform them of the patient's condition and treatment plan.
The short-term objective of this project is to test the efficacy of this intervention to reduce the transition from
acute to chronic musculoskeletal pain and reduce long-term opioid use and other key secondary outcomes.
This objective will be achieved via a three-arm randomized controlled trial with adults aged 50 years and older
who present to the ED with acute musculoskeletal pain. Patients will be randomized to (1) the full intervention
(video + telecare + communication with primary provider), (2) video alone, or (3) usual care. The primary
outcome will be pain, measured longitudinally over the course of a year following the ED visit. Secondary
outcomes will include opioid use, physical function, analgesic side effects and adverse events, depression and
anxiety symptoms, sleep duration and quality, and healthcare utilization at one, three, six, and twelve months.
We will also examine whether the intervention has its effect by promoting shared decision-making and assess
the cost-effectiveness of the intervention. The long-term goal of this work is to identify and implement effective
interventions into clinical care to improve outcomes for older adults with acute musculoskeletal pain.

Public health relevance
Project Narrative Older adults frequently experience acute musculoskeletal pain, are often inadequately prepared to select analgesics and identify recovery-promoting behaviors, and frequently experience persistent pain as a result of these episodes. The proposed study will test interventions to improve acute pain management decisions and reduce persistent pain among older adults using an interactive educational video shown to patient in the emergency department (ED), nurse-guided telecare shortly after the ED visit, and communication with a patient's primary care provider. The proposed research is relevant to public health and the priorities of the NIA, the NIH Pain Consortium, and NIDA because it will test interventions designed to reduce the transition from acute to chronic pain with the potential to reduce long-term opioid use.